Ambystoma Genetic Stock Center

OVERALL COMPONENT - PROJECT SUMMARY
The Ambystoma Genetic Stock Center (AGSC) at the University of Kentucky (UK) is the only federally funded
resource center that distributes laboratory axolotls (Ambystoma mexicanum), a salamander that provides living
materials in support of biomedical research nationally and internationally. Most notably, axolotls are unique
among vertebrates in being able to regenerate numerous tissues and body parts, including limbs and brain.
Since 2020, 31 different axolotl-associated projects have been awarded by NIH with support coming from
multiple institutes (NICHD, NHLBI, NIDDK, NIGMS, NINDS, OD, NEI, and NCI). NIH support is catalyzing
advances in biomedical research through its support of the axolotl and the AGSC, increasing the likelihood that
investigators will use axolotl models in the future.
During the 2025-2030 funding period, the AGSC will continue to generate and import high quality, axolotl
stocks and innovate new husbandry methods, services, and protocols. AGSC operations will be made more
efficient under a new data management plan that will enable multiple types of data to be recorded and
retrieved electronically and remotely. A new website will be created to provide curated information about AGSC
stocks, protocols for standardized husbandry procedures, protocols for pathogen monitoring, developmental
and life history information to aid experimental planning, execution, and reporting, protocols for laboratory
educational activities, and information to identify the best axolotl models for human disease. Web content will
be redundantly linked to facilitate searching within the website, and externally linked to outside gene orthology,
gene ontology, disease, animal model, and literature databases. The AGSC website will use surveys to obtain
customer feedback about AGSC products, and services, and a discussion forum will facilitate community
sharing of knowledge and data. Through these mechanisms, the new website will increase the visibility of
axolotl stocks and establish the AGSC as a critical source of information for advancing axolotl research and
educational efforts. In regards to outreach, the AGSC will offer a formal workshop to provide training in axolotl
husbandry and embryo microinjection at UK, and AGSC staff will develop and present educational activities in
local K-12 schools. In regards to applied research, 16S rRNA sequencing will be performed to increase
breadth of pathogen monitoring and generate baseline microbial data in support of microbiome research, both
of which will better ensure the health and reproducibility of AGSC axolotl lines. Finally, an axolotl disease
manual will be developed to provide a reference that axolotl labs can use to monitor pathogens and diagnose
common axolotl diseases. The manual will include protocols, assays, and treatments curated from the
literature and developed in house. Overall, the project will increase the AGSCs impact in biomedical research
and education, ensuring the distribution and long-term sustainability of axolotl resources to NIH-funded
investigators.

Public health relevance
PROJECT NARRATIVE This project seeks support for the Ambystoma Genetic Stock Center, an animal resource center that uniquely supplies axolotl salamanders for studies of organ regeneration, tissue repair, and post-embryonic development. Understanding the cellular and genetic mechanisms that axolotls use to regenerate tissues could have clinical significance for treating human trauma, disease, and aging.